AUTOMATED DNA SEQUENCER AND DNA SYNTHESIZERS

The Model 370 Automated DNA Sequencer and computer accessories and the two (2) coder 300 DNA Synthesizers are requested for the Immunology Program of the Sloan-Kettering Institute for Cancer Research. The Chairman, Dr. Osias Stutman, together with the 7 major user laboratories headed by Drs. Boyse, Cayre, Dupont, Flomenberg, Hammerling, Hoffman, Knowles, Lee, Old, Shen and Yang, represent more than 75% usage of the instrument.